Administrative

PROJECT SUMMARY /ABSTRACT According to literature pregnant women are at a greater risk for exposure and death during emergencies. The overall purpose of this proposed study will be to assess and describe how the isolation and physical distancing measures related to the current Coronavirus pandemic have affected pregnant women and mothers of children 12 months or younger in Puerto Rico. The specific aims of the proposed project are: 1) Examine the impact of the COVID-19 outbreak in pregnancy related experiences and outcomes; 2) Examine the mental health impact of the COVID-19 outbreak in pregnant women and mothers of children 12 months or younger; and 3) Identify risk and protective factors of pregnant women and mothers of children 12 months or younger in the COVID-19 outbreak. Participants will be recruited from the Puerto Rico Test-site for Exploring Contamination Threats (PROTECT) consortium cohort which is composed of pregnant women and mothers from the northwestern region of Puerto Rico that studies the effects of exposure to contaminants and preterm birth and other birth outcomes. The research will have two-phased mixed methods approach with an online-based quantitative survey and a series of individual semi-structured qualitative interviews. Results from the study will provide an assessment of the COVID-19 impact on pregnancy outcomes, mental health status as well as identify risk and protective individual and contextual factors among pregnant women and mothers of children 12 months or younger. The study findings will provide greater insight into the experiences and needs of Latino Hispanic pregnant women and mothers of children 12 months or younger during pandemics. We expect that the findings can lead to the development of interventions for community health centers around the island and also to the creation of evidence-based protocols aimed at the Puerto Rican population.

Public health relevance
PROJECT NARRATIVE Pregnant women and mothers of children 12 months or younger can be negatively impacted during emergencies, and while there is significant literature about maternal health and natural disasters there is a growing need to study maternal health in relation to pandemics like COVID- 19. In collaboration with the PROTECT Consortium, this project will provide quantitative and qualitative data that will allow us to better understand the impact of health emergencies like pandemics in the well-being of pregnant women and mothers of children 12 months or younger in Puerto Rico. Results from the study will provide empirical evidence to inform interventions aimed at pregnant women and mothers of children 12 months or younger as well as healthcare providers, institutional protocols for emergency preparedness with direct relevance to both the underserved population of Puerto Rico and the U.S. Hispanic Latino population.